CORE C Rabadan

Summary
Genomic techniques are revolutionizing the characterization of DNA alterations in cancer and
their relation to different DNA repair mechanisms. The Computational Genomics Core provides a
centralized structure to collect, analyzed and integrate data from all four projects. In addition to
current already implemented computational pipelines, the core will develop new techniques that
will be applied across projects, it will implement methods for data integration, provide quantitative
training and advise in statistical questions.

Public health relevance
The Computational Genomic core (Core C) will provide state-of-the art data analysis and integration for all 4 projects. It has become apparent that a rate limiting factor of high- throughput, genomics analyses is the ability to efficiently analyze large and complex datasets. By centralizing all analyses under the Dr. Rabadan leadership, the Core will greatly enhance research productivity of all Projects.